A systematic review and meta-analysis of anti-toxin treatments in animal models of live B. anthracis infection

Invasive B. anthracis infection is a relatively rare but highly lethal infection in humans. Production of lethal and edema toxin are believed to be central to the pathogenesis of B. anthracis infection. Due to the infrequency of invasive B. anthracis infection, but its potential use as a weapon of bioterror, the FDA permits the evaluation and approval of adjunctive therapy of this infection based on studies performed in at least two clinically relevant animal models. To what extent models that have been used to date to test anti-toxin agents have simulated the conditions encountered in patients presenting with invasive anthrax infection is unclear. Also, whether the effectiveness of anti-toxin agents is influenced when conditions do approach those encountered clinically (e.g. treatment after infection has manifested itself and in combination with other therapies) has not been investigated. To address these questions we are performing a systematic review of the literature and a meta-analysis of all preclinical models employing live B. anthracis challenge and testing anthrax anti-toxin treatments with or without accompanying antibiotic support. A manuscript has been accepted for publication. W. Xu, L. Ohanjandian J. Sun, X. Cui, D. Suffredini, Y. Li, J. Welsh, and P.Q. Eichacker. A Systematic Review and Meta-analysis of Preclinical Trials Testing Anti-toxin Therapies forB. anthracisInfection: A Need for More Robust Study Designs and Results. PLoS One